Leveraging Drosophila to identify novel and conserved regulators of cardiomyocyte polyploidy

ABSTRACT: During the transition to adolescence, mammalian cardiomyocytes switch from a proliferative phase
to a growth phase, primarily achieving expansion through whole genome duplication, also known as
polyploidization. Unlike most polyploid tissues, I have found that the Drosophila heart has rigid ploidy limits crucial
for optimal function. My postdoctoral work has revealed that the Drosophila cardiac organ has a chamber-specific
asymmetry to cardiomyocyte polyploidization, which I found is also conserved in humans. Altering this chamber-
specific asymmetry significantly impacts cardiac function in Drosophila, resembling human cardiomyopathies.
To identify conserved regulators of cardiomyocyte polyploidization, I used reverse genetics in
Drosophila to interrogate human cardiac chamber-specific gene expression differences. This genetic
screen, as well as subsequent screens described herein, identified conserved organ-specific and novel cardiac-
specific genes important for heart tissue ploidy regulation. This proposal builds on my successful screen to reveal
new molecular mechanisms of cardiac ploidy control. Utilizing Drosophila genetics, Optical Coherent
Tomography, immunofluorescence imaging and mammalian cardiomyocytes, I propose the following aims during
the K99/R00 phase: AIM1: Identify the mechanism of cardiac-specific ploidy regulation by COX7A (K99).
I identified cytochrome c oxidase subunit 7A (COX7A) as a heart-specific ploidy regulator. My hypothesis is that
COX7A functions as a specific regulator of cardiomyocyte polyploidization through repressing mitochondrial
production. AIM2: Identify the mechanism of cardiac-specific ploidy regulation by DZfand (K99/R00). I
identified the Zinc Finger Protein DZfand as a novel cardiac-specific ploidy regulator. My hypothesis is that
DZfand functions as a transcriptional regulator to negatively regulate cardiomyocyte polyploidization. AIM3:
Identify cardiac-specific function of Goliath ubiquitin ligases and other HF-linked GWAS genes in heart
diseases (R00). I found an enrichment of ubiquitin ligases in publicly available GWAS data for heart failure (HF),
which prompted me to conduct an Optical Coherence Tomography (OCT)-based reverse genetic screen of
Drosophila ubiquitin ligase genes. I identified that Goliath (gol/RFN150) ubiquitin ligases regulated cardiac
function. Hypothesis: Goliath ubiquitin ligases regulate cardiomyocyte polyploidization during heart failure (HF).
Building on the success of the OCT-based screen, I will expand this approach to screen for GWAS-
identified genes linked to HF in my independent phase. My work to identify novel cardiac ploidy regulators
using accessible Drosophila genetics is unique and crucial for understanding heart diseases, given that
cardiovascular diseases rank as the leading global cause of death. To successfully achieve these aims, I have
designed a training plan with my advisor, Dr. Don Fox, to acquire the necessary skills for transitioning to an
independent research role. Additionally, guidance from my advisory committee and collaborators will further
enhance my conceptual, technical, and professional abilities, facilitating this transition.

Public health relevance
PROJECT NARRATIVE: The precise regulation of cardiomyocyte polyploidization is vital for heart development and preventing heart failure. Through accessible Drosophila genetics, I have identiﬁed novel cardiac-speciﬁc ploidy regulators. My proposal to understand this new regulation and identify genes linked to cardiac disease is critical for addressing global heart health challenges, particularly given the high global mortality rates of cardiovascular diseases.